Administrative Core

PROJECT SUMMARY / ABTRACT
The Administrative Core will be led by the Center Director, Dr. Kristina Simonyan, who will be responsible
for the organization and overall operation of the Center. The External Advisory Committee will include five
clinicians and scientists from the fields of otolaryngology, neurology, speech-language pathology,
neurosurgery, and neuroimaging, who will provide oversight of the scientific progress of the Center and guide
the research plan as appropriate. The Administrative Core will pursue the following two specific aims: (1) to
integrate and support all Center components and scientific activities; (2) to provide regulatory and budgetary
oversight to the Center, and (3) to promote scientific discovery of the Center. The Administrative Core's
significance is in ensuring that there is a direct line of communication between the Center components, the
adherence to institutional and federal regulatory policies, the effectiveness of fund expenditure across the
Center, and timely dissemination of scientific knowledge derived from the studies of the Center.